Genetic studies of homologous recombination deficiency in hispanic gastric cancer

Scope of Work
Aim 1: To identify candidate single nucleotide polymorphism selection in Hispanic gastric cancer patients
and review discriminatory accuracy for polygenic modeling.ims in the project.
Aim 2: To investigate the association of germline single nucleotide polymorphisms with mutation
signatures and which has association in affecting the molecular subtype characterization of gastric
tumors.

Public health relevance
PROJECT NARRATIVE This proposal uses well-characterized Hispanic gastric cancer (GC) genetics studies to identify inherited GC causing mutations in the homologous recombination (HR) pathway and to characterize the somatic genome of tumors from Hispanics and from those that are HR deficient. GC is a leading cause of mortality in Hispanics and our study will generate a body of data that will be useful to address cancer disparities in this population. The supplemental efforts will use a variant selection approach in the building of polygenic risk scores to model and identify individuals most at risk at developing GC as well as a careful review of its association with molecular subtype.